IGF::OT::IGF ACA WEB PLATFORM TO INTEGRATE BEHAVIORAL HEALTH AND PREVENTION WITH PRIMARY CARE PERIOD OF PERFORMANCE 9/1/2015-8/31/2016: BASE AWARD

The Contractor will create an integrated multi-module system of web software tools to aid in behavioral health screening, prevention, triage, and tracking services in medical, school, and mental health settings.